Gene Expression and Manipulation Core

PROJECT SUMMARY - GENE EXPRESSION & MANIPULATION
The Gene Expression & Manipulation core is focused on providing support and assisting and facilitating specific
studies relating to gene expression and manipulation. Most of the types of studies supported by this core fall
within the range of ocular molecular biology, biochemistry, and cell biology. This includes evaluating,
quantitatively, the temporal effects of treatments, conditions or disease states on gene expression and protein
levels in ocular tissues. We also support studies focused on determining the effects of individual gene
manipulation on ocular processes and cells. This includes knockdown of specific gene expression levels in cells
or tissues by RNAi silencing, increases in specific gene expression by overexpression using vectors, and
modulation of activity or function of specific genes by expressing modified forms, e.g. by transfecting or infecting
genetic mutant, dominant negative, constitutively active, or alternatively spliced gene constructs. Manipulation
methods include construct transfection, gene or RNAi delivery via infection with recombinant viral constructs
such as lentivirus, or by lipid nanoparticles. We have recently been assisting investigators with CRISPR/Cas9
gene editing, including base and prime editing studies aimed at disease modeling with the intention of future
disease related modifications or stem cell manipulation. This core maintains various instruments that support
these types of studies. The core co-Directors and personnel have experience with all of these methods and will
facilitate and assist core users with any of the described techniques that they deem of value to their
investigations. In addition to providing this service to NEI-funded investigators, we actively support efforts of new
and young investigators, to develop pilot or preliminary data that can be leveraged into future foundation and
NEI funding.